The genetic and epigenetic etiology of progression from the precursor state to chronic lymphocytic leukemia (CLL)

Chronic lymphocytic leukemia (CLL) is the most common leukemia in the United States and still remains
incurable. Due to its impaired immune response, CLL has high number of morbidity and mortality
complications including increase risk of infections and second cancers. Therefore, identifying individuals who
are at markedly higher risk of developing this disease may enable future prevention strategies. Monoclonal B-
cell lymphocytosis (MBL) is the precursor state to CLL. The prevalence of MBL increases with age and is
found in almost a third of Caucasians older than 60 years. The prevalence of MBL in African Americans (AA)
is not well established. Although all individuals with CLL pass through the MBL precursor state, the reason
why some individuals with MBL progress to CLL yet many do not is unclear. Therefore, there is a need to
identify biomarkers that differentiate those MBL who will progress versus those who will remain asymptomatic.
The overall goal of this application is to address this knowledge gap by evaluating genetic and epigenetic
factors associated with risk of progression to CLL among an established cohort of 1,729 Caucasian individuals
with MBL. Importantly there is a widening equity gap with respect to our understanding of MBL and progression
to CLL in AA populations. Motivated by this, we will also take the initial steps to begin reducing this gap by
developing an MBL cohort of AA individuals through screening of 4,000 AAs and then undertake important
preliminary work of evaluating the genetic and epigenetic factors in our new AA MBL cohort. In Aim 1 we will
analyze the polygenetic risk score (PRS) comprised of a weighted average of 41 inherited single nucleotide
polymorphisms (SNPs) that have been previously identified through genome wide association studies (GWAS)
of CLL with risk of progression to CLL. In Aim 2 we will perform deep targeted sequencing of 59 putative CLL
driver genes to investigate if individual genes with high-impact mutations or the aggregate number of mutated
genes leads to an increased risk of progression from MBL to CLL. Finally, in Aim 3 we will evaluate whether
methylation signatures that classify MBL individuals into low-, intermediate-, and high-risk predict progression
to CLL. At the completion of this application, we will have identified three complementary yet independent
genetic and epigenetic factors that we hypothesize will be strong predictors of progression to CLL among a
cohort of Caucasian MBLs. Our preliminary data support our hypotheses. We have the largest cohort of
individuals with MBL collected in US, putting us in an unsurpassed situation to prospectively evaluate the effect
of known CLL risk factors at the precancer phase. Our integrative predictive model of all three biomarkers may
change current practice guidelines and ultimately improve quality of life by reducing anxiety and distress for
individuals in pre-malignant phase. Finally, because little is known about the generalizability of these genetic
and epigenetic factors in AA, we enhanced the significance of our application by taking the initial and vital
steps to build resources to begin the explorations of these genetic and epigenetic factors in AA individuals.

Public health relevance
Project Relevance to Public Health: We propose to evaluate genetic and epigenetic factors for progression to Chronic Lymphocytic Leukemia (CLL) in a large established cohort of Caucasian individuals who have the precursor condition called monoclonal B-cell lymphocytosis (MBL). To address the widening equity gap with respect to our understanding of MBL and progression to CLL in African American populations, we will also develop a newly formed African American cohort of MBLs in order to conduct exploratory analyses of these genetic and epigenetic factors. The results of our study may provide the development of a risk prediction tool that in turn may provide the development of new clinical recommendations for individuals with MBL; it will also provide needed initial data in African Americans with MBL.